The Bridge Clinic: Optimizing Injectable PrEP Delivery for Transgender and Non-Binary People

Project Summary/Abstract
Transgender and nonbinary (TNB) people are disproportionately affected by HIV, with increasing
numbers of new diagnoses from 2015-2019. Pre-exposure prophylaxis (PrEP) has great potential to reduce
new HIV infections, but has yet to improve HIV disparities among TNB populations. With the recent FDA
approval of long-acting injectable cabotegravir (CAB-LA) for PrEP, there is a critical opportunity to leverage this
scientific advance to increase PrEP use in TNB populations. In prior work, we piloted a flexible, low-
threshold, trans-affirming PrEP clinic (Bridge Clinic) which achieved higher PrEP uptake and reached TNB
individuals at higher risk for HIV acquisition than those receiving PrEP in gender affirming primary care clinics.
Key components of the Bridge Clinic model include a nurse-led PrEP clinic with flexible hours; PrEP
support provided by a trans peer navigator; text-messaging support via PrEPmate, a CDC-endorsed
evidence based intervention; transportation support; and a TNB community-led PrEP awareness
campaign. In this proposal, we will use Rapid-Cycle Research (RCR) methods to enhance the Bridge Clinic
to incorporate CAB-LA delivery, refine this model through iterative adaptations, and assess key implementation
outcomes. We will also evaluate for any drug interactions between gender affirming hormones and CAB-LA, an
important question to address for the TNB community. In aim 1, we will conduct a series of nominal groups
with English- and Spanish-speaking TNB people and semi-structured interviews with their providers to explore
patient- and provider-identified barriers and facilitators to CAB-LA delivery in the TNB community. We will also
elicit feedback on our implementation strategies to guide the enhancement of our protocol and engagement
approaches to incorporate CAB-LA. In aim 2, we will implement the CAB-LA Enhanced Bridge Clinic model
in an open cohort of 200 TNB individuals over a 3-year period, with mid-course adaptations guided by the RCR
process. Using the RE-AIM framework, we will assess the reach, effectiveness, adoption, implementation,
and maintenance of the Enhanced Bridge Clinic model via surveys and interviews with providers, staff, and
patients, and medical record data review. In aim 3, we will enroll a subset of participants receiving injectable
PrEP at the Bridge Clinic into two pharmacokinetic substudies to evaluate the bidirectional effects of gender
affirming hormone therapy and cabotegravir plasma concentrations in TNB individuals. Our work across aims
will be guided by a Stakeholder Advisory Board comprised of local and national community activists, leaders,
health professionals, and staff serving the TNB community who will meet quarterly to provide input on study
design and implementation, prioritization of adaptations, and ensuring the Bridge Clinic model is generalizable
to other practice settings. Upon study completion, we will have optimized and evaluated a novel PrEP delivery
model to increase uptake and persistence to long-acting injectable PrEP in TNB people, and assessed for drug
interactions between gender affirming hormones and CAB-LA in a real-world cohort of TNB individuals.

Public health relevance
Project Narrative Transgender and nonbinary (TNB) people are highly vulnerable to HIV and have lower use of pre-exposure prophylaxis (PrEP) for HIV prevention. This project will optimize and test a flexible trans-friendly clinic model for delivering long-acting injectable PrEP with CAB-LA, a recently approved medication that could greatly increase continued use of PrEP in TNB people. This study will also test for drug interactions between gender affirming hormones and CAB-LA, an important question that needs to be addressed for the TNB community.